Molecular basis of telomere dysfunction in cardiac dystrophy

Project Summary/Abstract
Duchenne Muscular Dystrophy (DMD) is the most common childhood form of muscular dystrophy and arises
from mutations in the dystrophin gene. DMD is associated with early loss of ambulation and respiratory muscle
compromise, followed by the onset of cardiac complications. Although cardiomyopathy is a major cause of
death in DMD patients, most therapeutic interventions have focused on skeletal muscle therapies. We recently
showed that telomere dysfunction in conjunction with the dystrophin mutation leads to significant structural and
functional cardiac defects in mice, with all of the hallmarks seen in DMD patients. The studies proposed here
will investigate telomere induced foci in dystrophic cardiomyocytes (Aim 1), identify the role of unknown
telomeric mechanisms leading to cardiac failure (Aim 2) and determine the extra-telomeric function of a
telomere protein (Aim 3). Understanding the mechanism acting in the progression of cardiac dystrophy will
provide new therapeutic possibilities. These studies will also form the foundation for future investigation of
similar telomeric mechanisms in other cardiovascular diseases.

Public health relevance
Project Narrative Humans with Duchenne Muscular Dystrophy (DMD) die young from cardiac failure but current therapeutics remain suboptimal, relieving only the late symptoms. The studies proposed here will assess the importance of telomere biology in the development and progression of cardiac failure, using new genetic mouse models. Our research is aiming to investigate the molecular mechanism of telomere dysfunction in DMD cardiomyopathy.